DOSIMETRY FOR ASSESSMENT OF EXPOSURE TO VOLATILE COMPOUNDS

The purpose of this project is to test the ability of current modeling techniques to analyze individual human dosimetry of inhaled volatile compounds.